Screening for Human Milk Oligosaccharides that Protect Infants from HIV Infection

TBD

Public health relevance
Although breast-feeding transmits the HIV-1 virus from mothers to their infants, breast milk contains compounds that protect a majority of infants from infection. Preliminary Results support our hypothesis that human milk oligosaccharides are part of this protective mechanism. We aim at identifying those individual human milk oligosaccharides that are most effective in reducing HIV-1 infection.